Leadership Administration Core

7. Project Summary: LAC
The Leadership and Administrative Core (LAC) will ensure the UM-OAIC provides support for training the next
generation of scientists pursuing research careers in aging, and the conducting of novel research directed by
the UM-OAIC goals of: 1) advancing an understanding of the mechanisms by which exercise, activity-based,
and multi-modal rehabilitation interventions directed at specific functional impairments affect multiple body
systems underlying functional performance and enable functional recovery; 2) developing and testing
interventions to restore function and minimize disability following acute disabling events and gradual declines
related to serious chronic diseases; and 3) preparing junior investigators and more established investigators
new to the field of aging to advance research that promotes health and independence in older adults with
disabling conditions.
The LAC combines the skills of three leaders (MPIs): 1) Jay Magaziner, PhD, MSHyg, an
epidemiologist and gerontologist, who directs the campus-wide UM Center for Research on Aging
(administrative/contact MPI): 2) Leslie Katzel, MD, PhD, a geriatrician scientist and director of the Baltimore
VAMC GRECC (MPI for medical direction); and 3) Alice Ryan, PhD, an exercise physiologist who works
between laboratory and clinical research (MPI for mechanistic research). These leaders will guide
multidisciplinary investigators in an integrated program that builds on the sciences and therapeutic applications
of exercise, physical activity, and rehabilitation.
The LAC receives advice on operations, resource allocation, progress, and strategies for expanding
aging research at University of Maryland Baltimore (UMB) from an External Advisory Board of national leaders
in aging research; an Internal Advisory Board of research and administrative leaders at UMB not part of the
UM-OAIC; and a Community Advisory Board of community members interested in the well-being of older
persons. A Research and Education Advisory Panel advises LAC, Pilot and Exploratory Studies Core (PESC),
and Research Education Core (REC) leaders on UM-OAIC’s research training activities, and reviews pilot and
development projects and faculty scholars. Internal and External DSMBs review data quality, patient safety,
and ethical conduct of research.
The LAC receives outstanding intellectual and financial support from UMB to achieve UM-OAIC
research and research training goals. The LAC fosters ongoing discussion among core leaders and faculty
scholars to ensure research and training are done in a cohesive, coordinated and integrated manner. The LAC
also engages scientists from across UMB so that research and research training can take full advantage of the
breadth and depth of experience and resources available. The LAC aims include: enriching the cadre of
translational scientists pursuing aging research; advancing the careers of junior faculty to become independent
investigators; developing resources to support goals; ensuring independent review of pilot, development
project and faculty scholar applications; and managing the UM-OAIC budget and distribution of funds.